Mentoring Investigators in HIV and Tuberculosis Therapeutics Research

SUMMARY
Tuberculosis (TB) is now the leading infectious cause of death globally, and it remains the #1 cause of
death among people living with HIV (PLWH). The first-line regimen is long and burdensome to patients
and programs, and drug-resistant TB typically requires treatment for 1-2 years with drugs that can cause
severe or irreversible toxicities. The TB drug development pipeline is now robust, providing reason for
optimism. To optimize current and new drugs, though, we must employ state-of-the-art drug
development approaches (including best use of quantitative pharmacology), and it is imperative that new
drugs or regimens be developed so that they can be used in all patients that may benefit from them,
including PLWH, children, and pregnant women. Critical challenges and opportunities lie in using
clinically pharmacology as a tool more effectively in TB and HIV therapeutics research, across the drug
development and optimization spectrum. This is the context for this application for a K24 Mid-Career
Development Award for Kelly Dooley, MD, PhD, Associate Professor of Medicine, Pharmacology, &
Molecular Sciences in the Divisions of Clinical Pharmacology and Infectious Diseases at Johns Hopkins
University, to provide protected time to mentor trainees in patient-oriented research in TB and HIV
therapeutics. Dr. Dooley is one of the few Infectious Diseases specialists with training in Clinical
Pharmacology working in the TB therapeutics field. She is a globally-recognized leader in TB and HIV-
associated TB treatment research and has mentored (and is mentoring) multiple trainees in the field.
Through the multiple independently-funded studies she is leading as well as those she is directing in her
capacity as a member of the TB scientific leadership committees of the ACTG, TBTC, and IMPAACT
networks, she is in a position to provide excellent opportunities to train the next generation of clinical
researchers in patient-oriented research in TB and HIV. In addition, this K24 will allow her to expand her
own knowledge in several key areas: quantitative pharmacology approaches, as applied to design and
analysis in clinical trials of TB or TB-HIV treatment; biomarkers identification and use as well as
understanding of drug delivery to hard-to-access compartments, for example in tuberculous meningitis;
and a new area of critical unmet medical need, the treatment of nontuberculous mycobacteria (in
patients with and without HIV). This K24 will allow Dr. Dooley to have the protected time to train the next
generation of investigators in clinical pharmacology and clinical research, as applied to TB and HIV-
associated TB, a critical shortage area; expand quantitative approaches in TB therapeutics work; and
explore new areas of investigation. The protected time afforded by this award is essential to Dr. Dooley
achieving these goals.

Public health relevance
PROJECT NARRATIVE This is a proposal for a K24 Midcareer Investigator Award in Patient-Oriented Research for Kelly E. Dooley, MD, PhD. This award will support Dr. Dooley’s mentorship of new and existing young investigators and her clinical research programs which are focused on improving tuberculosis (TB) therapeutics and optimizing treatment of HIV-associated TB, using clinical pharmacology as a powerful tool for doing so. The overarching goals of her research are to improve the treatment of drug-sensitive and drug-resistant TB, TB meningitis, and mycobacterial diseases, and to ensure new treatments are available to those patients who need them most, including populations such as children, pregnant women, and patients living with HIV, all through well-designed clinical research.